A deep learning-enhanced multiphysics and multiscale framework for predictive modeling of inflammation-induced thrombosis

As witnessed in Coronavirus disease 2019 (COVID-19) pandemic, inflammation-induced thrombosis could
lead to elevated disease severity, worsened clinical outcomes and increased mortality. In particular,
accumulating evidence from autopsies suggests that these thrombi are prevalent within the microvascular
of vital organs, such as the lungs, liver, kidney and heart, implying that microthrombosis may contribute to
the microvascular dysfunction and multi-organ failure in patients with severe cases of COVID-19. Although
many proinflammatory and prothrombotic factors associated with COVID-19 have been reported, how
these factors regulate the thrombosis in the microvasculature is elusive. Since the formation of
microthrombi cannot be observed directly in vivo, these is a lack of markers to assess the extent of
thrombogenesis and connect it to the clinical outcomes in time for appropriate therapeutic intervention.
In this application, we propose to develop a deep learning-enhanced multiphysics and multiscale framework
for predictive modeling of inflammation-induced thrombosis in infectious diseases. Using COVID-19 as
an initial disease model, we will examine the feasibility of using circulating cell clusters (CCCs) in the
blood samples of patients with COVID-19 as potential markers for disease prognosis. We will also
investigate the underlying mechanisms of the formation of microthrombi and CCCs as well as predict their
adverse effects in microcirculation. We propose to achieve our objectives through the following three Aims.
In Aim 1, we will develop a new deep learning model based on graph neural networks to automatically
analyze the flow cytometry images of CCCs from COVID-19 blood samples and explore the association
between CCC phenotypes and the specific clinical outcomes of patients with COVID-19. In Aim 2, we will
develop new deep learning models for coagulation pathways based on system-biology informed neural
networks to explore the mechanism for the activation of inflammation-induced coagulation. In Aim 3, we
will develop new multiphysics and multiscale models to simulate the formation of microthrombi and CCCs
as well as their dynamics in the microvasculature. The clinical data collected in Aim 1 will be used to
inform the computational models in Aims2&3 whereas Aims2&3 will provide mechanistic rationale for
findings in Aim 1 and offer insight for new treatment strategies.
In summary, the proposed predictive multiphysics and multiscale computational framework will provide
new computational and modeling tools to improve disease prognosis for COVID-19, elucidate the
pathogenesis of inflammation-induced thrombosis, identify the potential key factors that regulate the
thrombogenesis, thereby opening new avenues for developing more effective and tailored antithrombotic
treatments for hyperinflammatory prothrombotic disorders in various infectious diseases.

Public health relevance
As witnessed in Coronavirus disease 2019 (COVID-19) pandemic, inflammation-induced thrombosis could lead to elevated disease severity, worsened clinical outcomes and increased mortality. Due to the high biological safety risk, the blood samples of patients with infectious diseases are limited to access for in vitro experimental investigations of the mechanisms underlying the processes of thrombus formation. In this application, we propose to develop a new predictive multiscale and multiphysics framework enhanced with deep learning techniques to elucidate the connection between the pathogenesis of microthrombosis and the clinical outcomes of patients with COVID-19 and this proposed framework can be extended to test new hypothesis for hyperinflammatory prothrombotic disorders in various infectious diseases.